A Randomized, Double-Blind, Controlled, Multi-Center Trial of Colchicine in Calcium Pyrophosphate Deposition Disease

PROJECT SUMMARY/ABSTRACT
Calcium pyrophosphate deposition disease (CPPD) is a painful inflammatory crystalline arthritis that afflicts
8-10 million Americans, but targeted treatments do not currently exist and there are very few studies on this
common arthritis. Some patients with CPPD report improved joint symptoms with long-term colchicine 0.6mg
daily (FDA-approved dose for gout), though we currently lack tools to predict which CPPD patients will benefit.
The NLRP3 inflammasome plays a key role in the pathophysiology of CPPD and cardiovascular (CV) disease,
and CV risk is up to two-fold higher in patients with CPPD than matched comparators. Understanding
colchicine's impact on the NLRP3 inflammasome and downstream pathways will provide critical knowledge
about mechanisms by which colchicine reduces CPPD symptoms and has tremendous

Public health relevance
PROJECT NARRATIVE Calcium pyrophosphate deposition disease (CPPD) is a painful inflammatory crystalline arthritis that afflicts 8- 10 million Americans, but targeted treatments do not exist. Colchicine 0.6mg daily is sometimes prescribed for chronic CPPD treatment, though we currently lack tools to predict which CPPD patients will benefit. We will investigate colchicine's effect on inflammatory biomarkers, immune cell populations and transcriptional profiles in this first-ever randomized, placebo-controlled, long-term (12 month) trial of colchicine in CPPD.